Sociodemographic and geospatial disparities in outcomes for patients with biliary atresia: A comprehensive analysis using national and state datasets

PROJECT SUMMARY / ABSTRACT
Biliary atresia (BA) is the leading indication for pediatric liver transplant in United States and the leading indication
for any solid organ transplant in a child less than 1 year old. Affected infants are usually born healthy but develop
clinical manifestations of liver failure between 2 weeks and 2 months of age. Prompt diagnosis and surgical
intervention with the Kasai portoenterostomy procedure, which can restore bile flow and delay liver transplant,
are critical to short- and long-term disease outcomes. Unfortunately, factors that influence access to care,
including race, ethnicity, and socioeconomics, have been shown to influence age at diagnosis of BA and Kasai
procedure. These findings suggest an inadequacy in our current care paradigms and indicate that further work
is needed to fully understand how disparities are shaping unequal BA outcomes. Specifically, it is critical to
understand whether demographic, socioeconomic, and geographic factors influence disparities at additional time
points, such as prior to diagnosis, post- Kasai procedure, and in age at liver transplant. Further clarity as to these
outcomes will enable targeting of interventions and resources towards these time points, to enhance equity for
this vulnerable population of children. Therefore, we propose a comprehensive analysis of clinically significant
BA outcomes, at several time points along the disease continuum, stratified by race/ethnicity, neighborhood-
level socioeconomic advantage, and geographic factors. In Aim 1, we will link two national databases to examine
disease outcomes from Kasai surgery extending through liver transplant – including survival with native liver at
2, 5, and 10 years; readmissions after Kasai surgery; admissions for cirrhosis-associated conditions prior to
transplant; MELD at time of transplant; and overall survival. These outcomes have not been examined with
respect to race/ethnicity or socioeconomics. In Aim 2, we will examine a more granular statewide dataset
detailing all emergency department and hospital admissions for children in California. We will build a cohort of
infants diagnosed with BA across the state and examine outcomes within the first year of life, including age at
diagnosis, age at first surgery, cumulative emergency and hospital admissions both prior to and after diagnosis,
and survival without transplant at 1 year. The results of our analyses will indicate which sub-populations of
children with BA are suffering worse outcomes and where along the disease continuum these differences occur.
These findings will guide targeted interventions and policy decisions and will also equip me with specific skills in
health equity science, advanced statistics, and geospatial analysis to propel me towards my career goal as a
funded surgeon scientist.

Public health relevance
PROJECT NARRATIVE To advance health equity for children diagnosed with biliary atresia, the leading indication for pediatric liver transplant, a more comprehensive understanding of how race/ethnicity, socioeconomics, and geographic factors influence outcomes at different time points along the disease continuum is critically needed. This proposal will analyze both national and statewide datasets and examine how an infant’s racialization and sociodemographic milieu influences disease-specific outcomes, including access to specialized care, post-surgical complications, and timing of liver transplant. Our answers will highlight where targeted interventions should be directed to better support this vulnerable population.